The Biology and Biochemistry of Lipid Transfer Protein-Regulated Phosphoinositide Signaling

ABSTRACT/SUMMARY
The overarching objective of the proposed research is to understand how eukaryotic cells organize major
lipid signaling pathways, and how these do so in a manner that imparts both spatial and temporal specificity,
and specificity of biological outcome. The system of interest is phosphoinositide signaling and the general
question of how cells functionally channel a rather simple chemical code into a large diversity of biological
activities. The experimental goal is to execute a detailed functional analysis of two under-investigated
classes of proteins -- the phosphatidylinositol (PtdIns transfer proteins (PITPs) and the oxysterol binding
related proteins (ORPs) -- in control of such functional channeling. To that end, two conceptually linked
directions will be pursued that: (i) address cell biological, physiological and mechanistic questions related to
the activities of yeast Sec14-like PITPs and the structurally unrelated mammalian StART-like Class 1
PITPs, and (ii) how the yeast oxysterol binding related protein (ORP) Kes1/Osh4 functions as a specific
antagonist of Sec14-dependent phosphoinositide signaling in yeast and what role ORPs play in neural stem
cell biology.
The proposed studies will test specific hypotheses that relate to: (i) how fungal and mammalian
PITPs bind membranes and exchange their lipid ligands, (ii) the mechanisms by which individual PITPs
regulate specific steps of lipid metabolism in yeast and mammals (neural stem cells, melanoma and the
obligate intracellular parasite Toxoplasma) to diversify the biological outcomes of phosphoinositide
signaling, and (iii) how the oxysterol binding protein (OSBP)-related proteins work against Sec14-
dependent PtdIns-4-phosphate signaling in regulating Golgi phosphatidylinositol-4-phosphate signaling.
These studies will clarify key unanswered questions regarding the mechanism of function of PITPs, the
mechanisms by which both Sec14-like and StART-like PITPs couple lipid metabolism to PtdIns kinase
signaling, and more global ramifications of PITP functional interactions with ORPs. A growing number of
inherited neurodegenerative and neurodevelopmental diseases, and diseases of proliferative disorders (e.g.
cancer), are attributed to derangements in Sec14-like and StART-like PITP activities. Thus, the proposed
studies will provide both new and fundamental information that bears directly on molecular mechanisms by
which PITPs regulate and organize signal transduction in eukaryotes, and protect mammals from diseases
of deranged cell proliferation (cancer), neurodegeneration and type 2 diabetes in humans.

Public health relevance
PROJECT NARRATIVE The proposed research seeks to define a conceptual and mechanistic landscape for understanding how cells digitize and organize their lipid signaling programs. The general experimental focus rests on how the functional balance between phosphatidylinositol transfer protein and oxysterol binding protein family member activities controls phosphoinositide signaling and eukaryotic cell physiology from fungi to humans. The ultimate aim is to leverage that knowledge for the development of new approaches for treating neurological disorders, type 2 diabetes, and cancer.